Differential Roles of Prefrontal Cortical Interneurons in Drug Seeking after Withdrawal

PROJECT SUMMARY
Drug craving during prolonged periods of abstinence is a major factor driving repeated cycles of drug abuse.
Given the escalating prevalence of substance abuse, it is imperative to have a thorough understanding of the
brain circuit plasticity and associated molecular mechanisms that specifically underlie drug seeking.
Nonetheless, despite several decades of research, the neural circuit mechanisms underlying strong cravings
for drugs after abstinence are not fully elucidated. The medial prefrontal cortex (mPFC) is associated with
various complex behaviors including working memory, impulsivity, goal-directed action, and decision-making.
Given the diverse roles of the PFC and its efferent and afferent connections to limbic reward circuitry, the PFC
is capable of integrating and transmitting drug-relevant signals throughout the brain as the addiction
progresses. In particular, several reports show that ventral PFC subregions modulate drug-seeking and
extinction behavior and are a viable target for deep brain stimulation to reduce addictive behaviors. However, it
is largely unknown how PFC sub-circuitries contribute to drug addiction differentially and whether specific cell
types, especially distinct types of interneurons, within the PFC are differentially responsible for drug-seeking
after withdrawal and extinction. In this proposed research, we will investigate the role of different interneurons
in the infralimbic (ventral) cortex for the seeking and the extinction of cocaine after withdrawal in our newly
developed head-fixed drug self-administration paradigm. First, we will directly monitor the activity of different
types of interneurons, parvalbumin (PV)-, somatostatin (SST)-, and vasoactive intestinal polypeptide (VIP)-
expressing neurons, in infralimbic cortex (IL) during cocaine self-administration at single-neuron resolution
using multiphoton photon microscopy. Second, we will directly manipulate the activity of distinct interneurons at
the specific timing of drug self-administration to examine the causal roles of these neurons in drug self-
administration. Third, we will examine how cortical outputs are regulated by distinct interneurons during drug
self-administration. Excitingly, we already acquired preliminary results showing the differential roles of distinct
interneurons in cocaine self-administration. Overall, we believe that the successful completion of this project
will yield significant benefits by establishing a framework for the research of drug addiction in a circuit-specific
manner, as well as by facilitating the development of a treatment approach for drug addiction.

Public health relevance
PROJECT NARRATIVE A recurring difficulty in the treatment of drug addiction is the reinstatement of drug use even after a lengthy abstinence period. The purpose of this proposal is to exploit recent technical advancements in order to analyze and discover the neuronal adaptation in specific neural circuitry in the prefrontal cortex for the self-administration of cocaine. We believe that the exploration of the circuit mechanisms for drug seeking after withdrawal will be extremely useful for creating a framework for researching drug addiction in a circuit-specific manner and for devising a treatment strategy for drug addiction.